A High Content Screening Platform for High Throughput, High Content Imaging and Analysis

Project Summary/Abstract
The Moffitt Cancer Center & Research Institute, Florida’s only NCI-designated Comprehensive Cancer Center is
requesting funds to purchase Perkin Elmer’s ‘Opera Phenix’ Plus High Content Screening (HCS) imaging
System. HCS, the application of automated microscopy and image analysis initially found its place in oncology
research due to early applications that measured apoptosis. Now, HCS imaging systems are used in numerous
applications relevant to cancer research, including, cell morphology, cell proliferation, cell death, cell tracking,
subcellular localization, colocalization, cell metabolism, and drug discovery. Furthermore, multiple single endpoints
as well as phenotypic outcomes can be measured simultaneously in cell monolayers, microtissues, spheroids and
even whole organisms. Research labs at Moffitt Cancer Center (MCC) use many of these applications to
investigate the complex, multi-faceted nature of cancer biology; however, current imaging technology at MCC lacks
the combination of sensitivity and experimental throughput afforded by HCS systems, leading to datasets that lack
scope and/or image quality. To justify the need for a high throughput (HT)-HCS instrument, we present the
research of 10 major users and 3 minor users whose primarily NIH-funded research would be substantially
positively impacted by access to such an instrument. The Opera Phenix Plus HCS system from Perkin Elmer, Inc.
has been identified as the most suitable instrument, because it incorporates the necessary technology and software
to meet the diverse HCS needs of MCC faculty. This HCS platform is considered ‘best in class’ due to a number
of advanced hardware and software features, that when combined, provide high resolution images with minimized
spectrum cross-talk and true point confocality at unmatched acquisition speeds. When paired with onboard
environmental controls and robotic liquid/plate handling, the system is a complete HT-HCS tool. The built in
‘Harmony’ software grants access to more powerful image analysis functions including, 3D rendering, customized
analysis building blocks, and PhenoLogic machine learning. Our investigators will leverage the power of the Opera
Phenix Plus to unlock mysteries in cancer genetics and metabolism, interrogate the tumor micro-environment, and
screen for potential therapeutics. They will use high content, live-cell, multiplex fluorescence imaging of cells,
microtissues, and spheroids to generate multi-parametric data outputs, acquiring more quantitative data, more
efficiently, with the added benefit of reduced costs per experiment. If awarded, the Opera Phenix Plus will be
installed in the MCC shared resource Analytic Microscopy Core (AMC) facilitating widespread adoption of this
technology. The AMC staff possess the necessary Microscopy knowledge and experience to effectively operate
the instrument and manage large datasets. The principal investigator for this proposal, Dr. Patricia McDonald, is
formally trained and well experienced in HTS and HCS technology and will oversee the scientific direction of the
instrument. The PI, together with the AMC director and staff will train the user group on how to prepare HCS
experiments, operate the instrument, analyze images and execute HTS campaigns.

Public health relevance
Project Narrative This proposal is requesting funds to invest in a high content screening (HCS) imaging system for use in cancer research at H. Lee Moffitt Cancer Center and Research Institute to provide investigators with a powerful tool to facilitate discoveries in cancer genetics, metabolism, and therapeutics. Perkin Elmer’s ‘Opera Phenix Plus’ HCS system will be installed in the Analytic Microscopy Core, a shared resource that is accessible to all investigators at Moffitt Cancer Center and the surrounding scientific research community including the University of South Florida and other regional academic collaborators.